T35 NEI Medical Student Summer Research Training

Project Summary/Abstract
This application seeks to establish a T35 NEI Summer Research Program to enhance medical
student research training in the vision sciences at UT Southwestern Medical Center. The
proposed program will provide short-term training opportunities for medical students in basic
and clinical biomedical research focused in areas supported by the NEI.
Based on our extensive experience gained from other NIH Research Training grants, we will
develop a short-term training program in vision research for those medical students enrolled at
UT Southwestern as well as outstanding applicants from medical schools across the country.
Building upon our collective experience in the identification and pairing of students and mentors,
we anticipate that these experiences will continue to enrich the research background of
participating medical students with an interest in ophthalmology and vision science. In addition
to the mentor-based teaching within the laboratories and clinics, trainees will also receive a
comprehensive course in Research Methodology with NEI-specific journal clubs coordinated
and directed by the PD/PI and participation in a works-in-progress vision science seminar
series.
The program described in this application will employ the outstanding faculty and resources
already in place at UT Southwestern that are focused in areas of NEI interest. This program will
serve as a focal point to further enrich medical student research activities in the vision sciences
at UT Southwestern and will enhance existing elements of NEI-funded research on campus.

Public health relevance
Narrative In the last four decades, the great strides made in biomedical research has made training the next generation of physician scientists a critical element needed to translate biomedical discoveries into new therapies capable of treating and preventing human disease. The goal of the T35 NEI Summer Research Program is to identify highly-qualified pre-doctoral students (medical students) and educate them to pose scholarly questions and design methods of answering those questions to continue to advance the science of medicine through a mentored research experience and in-class educational opportunities.